RELIABILITY OF MAXIMAL RESPIRATORY PRESSURES IN MS

The goal of the study is to assess the reliability of measurement of maximal inspiratory (PImax) and expiratory pressures (PEmax) in subjects with multiple sclerosis (MS) by 1) identifying the number of repeated measurements that will achieve the maximal values of MS patients in a single session, 2) determining the number of sessions needed for subjects to learn the measurement, 3) comparing the number of repeated measurements of PImax and PEmax and number of sessions needed for MS patients and healthy control subjects to obtain maximal values, and 4) determining if level of fatigue, severity of disability secondary to MS, age, gender, and pattern of MS symptoms affect PImax and PEmax in patients with MS. These noninvasive measures of the strength of the inspiratory and expiratory muscles are the maximum negative and positive pressures which can be measured at the mouth, respectively. PImax and PEmax will be measured in this study using standard procedures and a magnehelic pressure gauge. Eighty-five subjects with definite MS and eighty-five healthy control subjects will be recruited. In order to determine the number of trials in a single session needed to produce maximum values, PImax and PEmax measurements will be each repeated a maximum of 10 times, until fatigue is reported, or until two consecutive pressures are reduced to less than 10 cm H2O of the maximum pressure obtained by that subject after three technically acceptable measurements have been obtained. The measurements will be obtained again one, two and three weeks later to determine the effect of learning on the measurements. Values obtained by MS subjects will be compared to those obtained by healthy control subjects. Fatigue level, neurological disability, age, gender, and pattern of MS symptoms will be assessed to determine their effect on PImax and PEmax. Correlation coefficients will be calculated to identify relationships of mode, range, mean and maximum values of maximal inspiratory and expiratory pressures with age, gender, extent of disability, extent of bulbar involvement, and fatigue level. Alpha reliability over 40 measures for each subject will be calculated to examine internal consistency of the measurements for the total sample and the group of MS subjects and control subjects. ANOVA will be used to examine similarities and differences of the MS patient group and the healthy control group.